Innovations in Functional B Cell Epitope Discovery for Lyme Disease

The goal of the proposal is to generate comprehensive human B cell epitope maps of major immunodominant surface lipoproteins of Borrelia burgdorferi, the causative agent of Lyme disease. Lyme disease is the most common vector-borne infection in the United States, with an estimated 450,000 cases per year. Epitope mapping lipoproteins on the surface of B. burgdorferi will advance the development of Lyme disease vaccines, therapeutics, and diagnostics in the United States and abroad.